Core A - Administration

Core A: Administration Project Summary/Abstract The Administrative Core supports the overall mission of the Center by freeing CDE affiliates to focus their efforts on the scientific aspects of their research and by supporting development, training, and dissemination activities. The Core's professional and specialized staff provides faculty affiliates with a full range of services to support grants submission and management and provides administrative support to the Development, Computing, and Data Cores. The Core plays an important role in all other Center activities including the development and implementation of long-term priorities and new initiatives, the effective and timely dissemination of important research findings, the coordination of training activities, and regular communication with affiliated centers to identify collaborative research opportunities and avenues for cost- sharing and efficiencies.

Public health relevance
Core A: Administration Project Narrative Core A provides the resources and support that allows CDE to function efficiently as a cohesive research center. All aspects of the Center's research and training mission depend upon the support provided by the Administrative Core. Core activities are also critical for the recruitment of new affiliates and to the Center's ability to respond flexibly and effectively to emerging research questions and opportunities.